Monoallelically expressed genes as a novel mechanism of genetic errors of immunity

Project Summary – Project 1
The transcription of autosomal genes is thought to occur from both inherited alleles, maternal and paternal.
However, it has recently become clear that approximately 1-5% of autosomal genes can be expressed from a
single allele in a random manner across the cells of a given individual. This restriction of allele expression, known
as autosomal random monoallelic expression (aRMAE), is established by specific chromatin marks during
development and remains stable, unaffected by mitosis, in the lineage concerned. Unlike X-chromosome
inactivation or genomic imprinting, allele selection is independent of other genes and may differ between
neighboring cells. Our understanding of this epigenetic phenomenon is growing, but the mechanism involved
has yet to be dissected in detail and its functional consequences remain unclear. It has been suggested that
aRMAE functions as a means of extending intercellular variability within an individual. This may facilitate the
maintenance of homeostasis, and regulation of the functional impact of deleterious mutations in cases of genetic
disease. In this respect, aRMAE may help explain phenotypic variation in genetic disease. Even in well-studied
Mendelian disorders, in which single-gene defects result in severe phenotypes, incomplete penetrance is often
observed. Environmental factors may account for some of the phenotypic variability observed but cannot explain
discordance between monozygotic twins or asymmetric disease manifestations within a single individual. Inborn
errors of immunity (IEIs) are the principal example of this phenomenon. Genetic errors of more than 500 unique
genes have been identified that underlie IEIs, a diverse class of monogenic diseases, often with incomplete
penetrance and disease expressivity among members of the same family with the mutated allele. This
phenotypic variability is common and remains a challenge in the study and clinical management of these
disorders. Our preliminary data suggest that aRMAE is a key determinant of IEI penetrance, but aRMAE has
never been systematically studied in IEIs. We plan to identify all the known all IEI genes displaying aRMAE, to
elucidate the epigenetic mechanisms governing this molecular process and to determine the phenotype
consequences of aRMAE in IEI patients. The identification and dissection of mechanisms governing aRMAE in
IEIs should reveal novel genetic principles underlying pathophysiology.